Center for the Study of Tobacco Products

Project Summary. The Center for the Study of Tobacco Products (CSTP) has developed a model for
evaluating novel tobacco products using, as exemplars, electronic cigarettes (ECIGs) that heat a liquid that
often contains nicotine, forming an aerosol that users inhale. Now, CSTP leverages its methodological and
ECIG expertise to pivot from product evaluation to an integrative theme of impact analysis. FDA tobacco
regulation must protect public health, though regulations may also have unintended consequences that cause
harm. For example, limiting ECIG liquid nicotine content, as in the European Union, can drive use of higher
power ECIGs that aerosolize more liquid, leading users to inhale more nicotine and other toxicants. Other
potential ECIG regulations involve constraining amount of nicotine emitted/unit time (nicotine “flux”) that may
influence product toxicity and abuse liability, or reducing flavor availability that may lead users to mix their own
flavored liquids. If FDA could predict a potential regulation’s effects, then refinements before the regulation is
issued might maximize its health-promoting effects and minimize unintended consequences. Methods exist for
assessing a regulation’s effects once it is in place, but few data-driven models predict impact beforehand. Any
such model must draw from several domains to assess how a potential regulation might change product
toxicity, user behavior, and addiction/abuse liability. Also, the model must demonstrate the extent to which
predictions about potential regulatory effects describe actual population-level outcomes. CSTP addresses this
issue with this application: Projects 1-3 will test hypotheses and generate predictions regarding the impact of
three potential ECIG regulations (i.e., limit nicotine, constrain flux, reduce flavor availability); Project 4 will test
these predictions at the population level. CSTP’s vision is to provide tools to guide regulation development so
that, by the time a regulation goes into effect, validated methods have tested it, refined it, and generated data
showing that its health-promoting effects are maximized and unintended consequences minimized.
The team (Drs. Eissenberg, Breland, Shihadeh, Cobb, Barnes, Cohen, Fagan) will complete 4 integrated
projects that aim to: predict product toxicity, predict user behavior, predict abuse liability, and assess potential
regulation impact. A Contextual Knowledge Core uses mixed methods to ensure Projects 1-4 reflect the real
world. A Career Enhancement Core conducts a tobacco regulatory science course, supports pre- and post-
doctoral appointees, and pilot projects. An Administrative Core supports financial/managerial processes,
biostatistical needs, receives input from an External Advisory Board, and interfaces with FDA, NIH, and others.
Overall, CSTP’s integrative theme of impact analysis draws on the team’s expertise in tobacco product toxicity,
user behavior, and abuse liability. We seek to provide FDA with hypothesis-driven data regarding advanced
generation ECIGs and test predictions about some potential regulations now, while developing a model that
can be used to shape, refine, and predict the effects of many potential regulatory actions in the future.

Public health relevance
Project Narrative. The CSTP seeks to provide FDA with hypothesis-driven data regarding advanced generation ECIGs and test predictions about some potential regulations now, while developing a model that can be used to shape, refine, and predict the effects of many potential regulatory actions in the future. Overall, CSTP’s integrative theme of impact analysis draws on our expertise in tobacco product toxicity, user behavior, and abuse liability to provide FDA tools that can be used to guide regulation development so that, by the time a regulation goes into effect, methods predictive of population-level phenomena have tested it, refined it, and generated data that show that its health-promoting effects are maximized and unintended consequences are minimized.